Iowa Department of Inspections & Appeals MFRPS Maintenance

MFRPS OVERALL SUMMARY/ABSTRACT
This funding opportunity will allow Iowa Department of Inspections & Appeals (DIA) the capability to
advance the efforts for a nationally integrated food safety system (IFSS) by meeting objectives of the
Manufactured Food Regulatory Program Standards (MFRPS) and Food Protection Task Force (FPTF).
DIA, as part of this application will maintain full conformance with the MFRPS, provide FDA the
foundation for pursuing regulatory action based on findings of state manufactured food regulatory
programs, continue to promote continuous improvement of the Standards, provide sample collection to
and maintain capacity of State Hygienic Lab (SHL) as well as demonstrate the ability to follow-up on
activities based on sample results, and develop strategies for achieving and maintaining conformance
that can be duplicated nationwide.
DIA will support an Iowa Food Protection Task Force (IFPTF) that provides a forum for all key food
stakeholders to share information and promote integration through collaboration. The main objective
for the IFPTF are to support routine communication between stakeholders, discuss foodborne illness
prevention, intervention, and response as well as work together to achieve compliance with FDA Food
Code and Code of Food Regulations.

Public health relevance
MFRPS OVERALL PROJECT NARATIVE The Iowa Department of Inspections & Appeals (DIA), Food & Consumer Safety Bureau intend to maintain implementation and conformance with the Manufactured Food Regulatory Program Standards (MFRPS) and ensure that continuous improvement of standards is documented. Iowa also seeks to maintain the Iowa Food Protection Task Force (IFPTF) that provides a forum for stakeholders to share information and promote integration through collaboration.